CENTRAL NERVOUS SYSTEM MANIFESTATIONS OF THYROID HORMONE DIESEASE

This study will determine whether sleep parameters are altered in hyperthyroid patients and, if so, whether the abnormalities return to normal during the treated, euthyroid state.